Multi-omics profiling of individual exosomes for their origin-tracing, biomarker discovery, and biological function characterization

PROJECT SUMMARY / ABSTRACT
Exosomes, the small extracellular vesicles (30-200 nm), are highly heterogeneous in biofluids. However,
traditional bulk-level analysis approaches fail to represent their individual variations. A technique for multi-omics
profiling of exosomes at single-particle resolution is of great interest to the exosome research field, but has yet
to be developed. WellSIM proposes to develop and validate a method for multi-omics profiling of individual
exosomes based on our exosome isolation system (EXODUS), a droplet-based microfluidic device (EXOSeq),
and next-generation sequencing (NGS). Our proposed technique will be the first integrative proteomic and
transcriptomic profiling of exosomes at the single-particle level, offering high-resolution multi-dimensional
biological insights for exosome study and application.

Public health relevance
PROJECT NARRATIVE The conventional exosome characterization approaches usually analyze entire exosome populations, which cannot reveal the exosome heterogeneities or quantify exosome subpopulations in biofluids. Our proposed technique could address the unmet need for multi-omics single-exosome studies, offering substantial benefits to the EV research community. Its unprecedented resolution and sensitivity for exosome interrogation will facilitate exosome-based biomarker discovery and detection. This technique will also enable characterization of exosome subpopulations and their tissues of origin, as well as improve our understanding of exosome biogenesis and biological functions.